GENETIC APPROACHES TO AGING RESEARCH

DESCRIPTION: Five years of support are requested by the UW to provide in-depth training and research experiences for ten predoctoral and ten postdoctoral trainees in the area of genetic approaches to aging research. The goal of the program is to provide research training on the molecular genetic approaches to the biology and pathology of aging, with special emphasis upon a variety of model organisms and cell cultures that are amenable to genetic analysis (S. cerevisiae, C. elegans, M. domesticus, H. sapeins). Such materials are designed to permit trainees to address fundamental mechanisms relevant to aging and age-related diseases, including Alzheimer's disease (AD) and cancer. Didactic experiences will include courses in biochemistry, genetics, cell biology and pathology; journal clubs; review of on-going research (approximately 60 individual and six program projects, LEAD or center grants in aging); a course on "Molecular Genetic Approaches to Aging"; and bi-monthly meetings of the "Aging Journal Club". In addition, trainees will typically participate in weekly laboratory meetings and in individual conferences with their mentors. Research projects will include efforts to identify genes related to various forms of familial and sporadic AD, delineation of mechanisms of beta (B) amyloidosis and of its suppression, the role of Werner's syndrome helicase gene in aging and cancer, studies of free radical injury and defense in relation to aging, DNA damage and mutation in aging, and mechanisms underlying the limited replicative potential of somatic cells.